Neural Signatures of Bipolar Disorder across Depression and Remission

Project Summary Bipolar disorder is characterized by variability in mood symptoms and cognitive impairment which leads to functional impairment both during depression and even during periods of remission. A major clinical challenge is that patients exhibit substantial variability in treatment response despite having the same clinical diagnosis, which suggests heterogeneity in underlying neurobiological dysfunction. In this R03, our aims are to deﬁne speciﬁc frontal- cingulate cognitive control and amygdala-frontal emotion regulatory neural clusters in brain activation and connectivity using dimensional tasks of cognitive control and acute threat. We will also develop neurocognitive and emotional proﬁles of the neural clusters we identify. To accomplish our aims, we will analyze an existing dataset of functional magnetic resonance imaging (fMRI) scans, obtained in previous NIMH studies at the UCLA Mood Disorders Research Program, from bipolar disorder subjects (65 remitted and 21 depressed) and 65 healthy controls. We will use a novel approach, called Dimensional Neural Clustering, to classify fMRI data. Our approach is based on techniques used in other serious illnesses with multiply- determined outcomes, such as breast cancer, that have revolutionized treatment by identifying subgroups and made invaluable life-saving contributions. After computing brain activation and connectivity associated with the neural circuits underlying cognitive control (activated by response inhibition) and acute threat (activated by emotion regulation), we will use Dimensional Neural Clustering to identify subgroups of patients. Dimensional Neural Clustering differs from previous machine-learning approaches because we will use neurobiology to deﬁne subgroups of patients, rather than to classify patients based on a clinical diagnosis. We hypothesize that patients can be classiﬁed based on inhibitory and regulatory neural clusters. Moreover, the neural clusters will be associated with differential phenotypic expression characterized by neurocognitive performance, mood/anxiety symptoms, and the ability to reappraise/suppress emotion. Our demonstration of neural subtypes of bipolar disorder will provide a basis for a neurobiologically-driven approach to understanding bipolar disorder, on which we can elaborate in future dimensional work. Our ﬁndings will provide a foundation for future work to personalize treatment.

Public health relevance
People diagnosed with bipolar disorder experience different disease symptoms and have varied responses to treatments for depressive episodes. Such variability within patients who have the same clinical diagnosis suggests signiﬁcant underlying neural heterogeneity that is not captured by current diagnostic criteria. We will implement a novel approach that uses functional neuroimaging data to generate a neurobiologically-driven classiﬁcation of people with bipolar disorder to guide future work in personalizing treatment.